GEREF TO TREAT SHORT, SLOWLY GROWING CHILDREN WITH NORMAL GH RESPONSE

The purpose of this study is to determine the effectiveness of Geref in treating short, slow growing children who have normal GH response; whether growth is sustained 6 months after discontinuing injections; whether the medication is well tolerated and safe.